Overcoming Barriers to Bioengineering 3-D Human Lung

DESCRIPTION (provided by applicant): The overall goal of this application is to define conditions that are conducive to generating transplantable, 3-D human lung. Major obstacles to lung transplantation include the paucity of donor lungs available, chronic rejection the requirement for lifelong immunosuppression and high mortality. A new source of transplantable lung tissue that will not be subject to rejection is needed. Using decellularized lung matrix (DLM) as the natural foundational scaffold, our central hypothesis is that building functional, transplantable lung requires a combination of geometry that allows for appropriate cell localization and biomimetic cues superimposed on cells as they align to drive functional integration and maturation. The PI of this application developed a decellularized, ventilated lung bioreactor system that supports the growth of fetal lung cells and is amenable to evaluation of the potential to rebuild the lung. In addition to the use of DLM, the novelty of this proposal entails the use of autologous cells with lung recellularization potential all from the same BM source, i.e. all cells are autologous to each other and have the potential to be used in translational clinical studies. Post natal/adult human iPS cells are cells that have been reprogrammed to have characteristics of embryonic stem cells. We have evidence that DLMs can be seeded with induced pluripotent stem cells (iPS cells) that give rise to alveolar type II-like cells. We wish to evaluate the use of autologous BM-derived mesenchymal stromal cells (MSCs) and iPS-derived endothelial cells (ECs) in completing the recellularization of DLM. A team of investigators representing a convergence of the fields of bioengineering, pulmonary biology, physiology, stem cells, vascular biology and thoracic surgery has been assembled. Our aims encompass the recellularization of DLM in a developmental stage-appropriate manner that results in correct cell patterning with tight junctional barriers, gas exchange and fluid clearance functional properties. We will take a stepwise approach to determine the contribution of matrix geometry, physiological stretch and vascularization on re-epithelialization and function of recellularized constructs using human autologous progenitors and compare to native lung. We reason that by comparing different conditions head-to-head and in combination, several fundamental rules for bioengineering an autologous functional lung will be defined. There are 3 Specific Aims in this proposal. In Aim 1 we will determine the contribution of matrix geometry and physiological mechanical stretch on the differentiation of human progenitor cells into pulmonary cells. In Aim 2, we will evaluate if recellularization of DLMs is best achieved with mesenchymal induction using BM-derived MSCs. Aim 3 will determine if prior endothelialization of the DLM vascular network potentiates subsequent epithelial progenitor cell attachment to DLM, differentiation and function. We will use BM-derived endothelial cells (ECs) infused through the vasculature access to re-endothelialize DLM. Since vessels are stabilized by pericytes that are of MSC origin, we will use human BM-derived MSCs to study if they can potentiate the attachment of ECs. (End of Abstract)

Public health relevance
Project Narrative Lung transplantation is usually the only option for patients with irreversible structural lung damage but is hindered by two major obstacles - a lack of lung organ donors and chronic rejection after transplanatation. We will focus on rebuilding 3-D human lungs using ventilated, decellularized (i.e. all cells are removed) whole pig lungs as a natural 3-D matrix framework that is very similar to human lung matrix in structure and function. We will repopulate it with human adult stem cells having the potential to grow into lung tissue and produce proteins characteristic of healthy lung cells. __SpecificAimsTextDelimiter__ SPECIFIC AIMS The overall goal of this application is to define conditions that are conducive to generating transplantable, 3-D human lung. Since transplantable trachea has reached the clinic[1] there is more interest in bioengineering the lung for repair and transplant.[2]. Major obstacles to lung transplantation[3-6] include the paucity of donor lungs available, chronic rejection [7-8] (lungs are not HLA-matched), the requirement for lifelong immunosuppression and high mortality. A new source of transplantable lung tissue that will not be subject to rejection is needed. Bioengineering lung with artificial scaffolds cannot replicate the branching, composition and mechanical properties of the extracellular matrix (ECM) that is between the air-liquid interface. However, we have shown that lungs can be decellularized to yield acellular ECM and vascular conduits while maintaining the correct geospatial branching pattern. Using decellularized lung matrix (DLM) as the natural foundational scaffold, our central hypothesis is that building functional, transplantable lung requires a combination of geometry that allows for appropriate cell localization and biomimetic cues superimposed on cells as they align to drive functional integration and maturation. We have a team of investigators representing a convergence of the fields of bioengineering, pulmonary biology, physiology, stem cells and vascular biology. The PI of this application developed a "decellularized, ventilated lung bioreactor" system that supports the growth of fetal lung cells and is amenable to evaluation of the potential to rebuild the lung[9]. The Co-PI is a pioneer in using decellularized whole organs, was the first to document recellularization of acellular hearts[10]and provides vascular expertise. We know DLMs can be recellularized with mature whole lung cells, implanted and participate in gas exchange, albeit with problems of hemorrhaging and edema, as recently demonstrated in rats by 2 labs[11-12]. What we don't know is how to recellularize lungs with autologous progenitors in a developmental stage-appropriate manner that results in correct cell patterning with tight junctional barriers, gas exchange and fluid clearance functional properties. We have evidence that DLMs can be seeded with induced pluripotent stem cells (iPS cells) that give rise to alveolar type II-like cells. We will take a stepwise approach to determine the contribution of matrix geometry, physiological stretch and vascularization on re-epithelialization and function of recellularized constructs using human autologous progenitors and compared to native lung. We reason that by comparing different conditions head-to-head and in combination, several fundamental "rules" for bioengineering an autologous functional lung will be defined. Aim 1: To determine the contribution of matrix geometry and physiological mechanical stretch on the differentiation of human progenitor cells into pulmonary cells. Our approach will be to use human bone marrow (BM)-derived iPS cells that have the potential to be used in translational clinical studies. We will compare culturing iPS cells in intact DLM vs homogenized DLM gels with developmental stage appropriate factors that recapitulate lung development (activin, Wnt 3a, FGF-2 and FGF-10). This will be done under different degrees of mechanical stretch that mimic fetal and adult lung physiology and compared to no stretch. Aim 2. To determine if recellularization of DLMs is best achieved with mesenchymal induction. Using the best conditions identified from aim 1, we will co-culture iPS cells with MSCs to determine if MSCs potentiate the differentiation and recellularization of DLM. Aim 3. To determine if prior endothelialization of the DLM vascular network potentiates subsequent epithelial progenitor cell attachment to DLM, differentiation and function. We will use BM-derived endothelial cells (ECs) infused through the vasculature access to re-endothelialize DLM. Since vessels are stabilized by pericytes that are of mesenchymal stromal cell (MSC) origin, we will use human BM-derived MSCs to study if they can potentiate the attachment of ECs (Aim 3A) and if ECs+/- MSCs can potentiate attachment and differentiation of lung epithelial cells or progenitors on DLM (Aim 3B). We will use the best conditions identified in aim 1 and the best (or best combination of) iPS cells and/or MSCs identified in aim 2 infused through the airway access.